Getting Excited about Cortical Malformations: Discovering the Mechanisms Leading to Seizure-prone Neurons in Malformations of Cortical Development

Abstract
Background: Following surgical resection for intractable epilepsy caused by malformations of cortical
development (MCDs), over 30% of children continue to have life-changing seizures. Mutations in genes of the
mechanistic target of rapamycin (mTOR) pathway lead to these disorders that include focal cortical dysplasia
(FCD), tuberous sclerosis complex and hemimegalencephaly. Therefore, there is a critical need to discover the
specific mechanisms by which increased mTOR signaling leads to the development of epilepsy to develop
specific therapies for children with MCDs. The central hypothesis of this proposal is that mTOR pathway
upregulation in pyramidal cells causes axon overgrowth, creating an epileptogenic network in both mouse and
human MCDs
Methods: The first step in testing the central hypothesis will be to determine the effect of mTOR pathway
upregulation on axonal length in mouse FCD and human MCDs via quantifiable analysis of fluorescently labeled
murine axons of and by 3D reconstruction of individually filled human neurons. A second set of experiments will
be performed to determine whether some pyramidal neurons act as operational hub cells in human and mouse
MCDs. Calcium imaging on ex vivo brain slices of mouse and human tissue will be used to define the local
network connectivity and identify hub cells. Finally, axonal degeneration will be induced in vivo in dysplastic cells
in mouse FCD to determine the effect of targeted reduction in axon length on seizure frequency.
Implications: The proposed research will help to determine whether axonal overgrowth is a key mechanism
by which mTOR upregulation leads to the generation of pharmacoresistant epilepsy in children with MCDs.
Additionally, this project will demonstrate whether targeting axonal overgrowth offers the potential for treatment
of seizures. Thus, the results of this research will provide further biological understanding of MCD and provide
hope for rational development of future successful therapies for children with this set of disorders.
Career Development Plan: During the five years of this award, Dr. Alexander will work with a team of
mentors to achieve six specific career goals which allow her to accomplish this project and will also cement her
transition to independent investigator. With hands-on mentorship and a focused set of coursework, she will work
towards three training goals. These are as follows: 1) to obtain training and mentorship in the principles and
techniques of molecular neuroscience; 2) to obtain mentorship and training in neuronal network analysis using
calcium imaging; and 3) to obtain training and mentorship in laboratory management as a neurosurgeon-
scientist. Dr. Alexander is a pediatric neurosurgeon at Children's Hospital Colorado. Her chairman and division
chief continue to support 50% protected time through on-campus resources which include dedicated research
space, a rodent EEG core, shared equipment and a startup package for laboratory equipment and personnel.

Public health relevance
Project Narrative Childhood epilepsy is a common and often devastating disease, and chronic seizures lead to a significant increase in premature mortality and developmental delay. A substantial proportion of children with Malformations of Cortical Development (MCDs) experience medically and surgically refractory seizures. This project will determine whether elongated axons, caused by known genetic changes, directly contribute to the untreatable seizures in children with MCDs and are thus a potential therapeutic target.